A Longitudinal Evaluation of Psychophysiological and Motor Dysfunction following Concussion: Associations with Subsequent Injury

PROJECT SUMMARY: Concussions are a significant health problem, with their incidence increasing largely
due to a significant rise in adolescents. While most concussions resolve within two weeks, presentation is
heterogeneous, and standard clinical assessments have yet to identify a true recovery window.
Psychophysiological measures have the power to elucidate lingering and subtle sensorimotor and cognitive-
affective impairments. These impairments may contribute to the increased risk (~2x) of subsequent
musculoskeletal (MSK) injury observed in the months following concussion. However, the underlying
mechanisms of the concussion-MSK injury relationship have yet to be fully established, leaving a critical need
to illuminate potential deficits. This may ultimately identify who is at risk for acute subsequent MSK injury
following concussion. The long-term goal of this proposal is to simultaneously characterize the persistence of
concussion-related sensorimotor and cognitive-affective deficits while laying the foundation for identifying
effective, clinically feasible markers of elevated MSK injury risk following concussion. The primary objective of
this NINDS R01 application is to examine the utility of psychophysiological measures for detecting lingering
sensorimotor and cognitive-affective deficits following concussion. Further, we will investigate their association
with future risk for subsequent acute MSK injury. The rationale behind this proposal is our preliminary data,
which demonstrates a suppressed brainstem-mediated general startle (GS) response following concussion,
compared to healthy athletes. This suppressed GS provides evidence of post-concussion brainstem
dysfunction and may reflect the lingering sensorimotor deficits that could be driving the elevated acute MSK
injury risk. Additionally, risk for injury may also be influenced by higher order brain structures that project onto
the brainstem and potentiate startle (SP) in response to unpredictable, environmental threats. Our preliminary
data also indicates an exaggerated SP after concussion. Given that unpredictable threats in sports often come
with higher injury risk, an exaggerated response may lead to high-risk movements and behaviors. This
research study will pursue three primary specific aims: to use validated NIH psychophysiological measures
longitudinally to (1) examine GS as a marker for lingering sensorimotor impairment in post-concussion
adolescent athletes compared to both their own premorbid GS and healthy controls, (2) examine SP during
unpredictable threat as a marker for lingering cognitive-affective impairment in post-concussion adolescents
compared to both their own premorbid SP and healthy controls, and (3) investigate the utility of GS and SP as
moderators of the increased subsequent acute MSK injury seen following concussion. This proposal is
innovative in that it will use a pre-post, longitudinal approach to elucidate psychophysiological dysfunction and
risk factors for subsequent acute MSK injury following concussion. This proposal is significant as it will further
aid clinicians in identifying adolescent athletes who are at increased risk of post-concussion MSK injury.

Public health relevance
PROJECT NARRATIVE Standard clinical assessments are unable to detect subtle post-concussion psychophysiological deficits, which are thought to contribute to increased risk of future injuries. The three aims of this project will 1) examine general startle as a psychophysiological marker of lingering sensorimotor impairment following concussion, 2) examine startle potentiation during unpredictable threat as a marker for lingering cognitive-affective impairment following concussion, and 3) examine the effects of psychophysiological measures on the concussion-related increase in acute musculoskeletal injury in adolescent athletes. Our aims will delineate underlying mechanisms of concussion pathophysiology and subsequent acute injury, which promises to inform readiness to return to sport decisions, clarify a more precise recovery window following concussion, and identify precise intervention targets.